The Contribution of Microglia to Neurodevelopmental Dysfunction in Down Syndrome

PROJECT SUMMARY
Down Syndrome (DS), caused by trisomy of chromosome 21 (Chr21), is the most common chromosomal
condition with over 200,000 individuals carrying the diagnosis in the US alone. DS, which is a multisystem
disorder, is notably characterized by intellectual and developmental disability as well as immunological
dysfunction. The association between the cognitive and immune disruption observed in patients with DS
remains to be elucidated. Based on mounting evidence implicating i) important microglial contributions to
neurodevelopment ii) microglial activation in individuals with DS and iii) our preliminary findings of DS
microglial inflammation and differential impact on brain environment in our models, this proposal is built around
the central hypothesis that microglia contribute to the neurodevelopment of DS.
The contribution of innate immune activation to DS pathology is poorly understood. Individuals with DS have
increased incidence of both infection and multiple autoimmune disorders. Chromosome 21 carries the genes
that encode four interferon (IFN) receptors in addition to other IFN response elements, which is proposed to
contribute to the prominent immune dysfunction in DS. Microglia are a key regulator of the neuroimmune
response and are modulated by IFN activation. Therefore, the project goal is to test the hypothesis that
microglial activation related to IFN signaling contributes to neurodevelopmental phenotypes in vitro (Aim 1),
and in a xenotransplantation model in vivo (Aim 2) resulting in microglia pathology and neuropathological and
DS-associated behavioral defects. This microglial pathology will be further dissect in Aim 3, where the impact
of DS on microglial heterogeneity and genome architecture will be queried to identify candidate transcription
factors driving microglial dystrophy in DS. The long-term goal is to identify the contribution of microglia
pathology to the DS neurodevelopmental phenotype, allowing for the elucidation of potential novel therapeutic
targets of the most common cause of developmental and intellectual disability in the US.
The proposed research will take place in the Coufal and Glass laboratories at UC San Diego. The Coufal lab
lends expertise in human induced pluripotent stem cell models of neuroimmunology, and the Glass lab has
extensive experience in macrophage gene regulation. Through graduate coursework, mentorship, and hands-
on learning, Genevieve will gain experience in approaching large datasets from a quantitative prospective and
will learn cutting edge wet lab and behavioral neuroscience techniques; these skills will be valuable for the
completion of the proposed research and for Genevieve’s future career as a physician-scientist.

Public health relevance
PROJECT NARRATIVE Understanding how trisomy 21 regulates microglial function and therefore neurodevelopment is critical to understanding how Down Syndrome develops. This proposal will examine how microglia derived from individuals with Down Syndrome differ in their phenotype and brain maturation functions. The ultimate goal of this proposal is to gain insight into the microglial dysregulation in Down Syndrome neurodevelopment and to identify mechanisms for potential therapeutic interventions for the disorder.